Tracking the evolution of breast cancer through single cell analyses of premalignant breast tissues from women at high risk for cancer development

Abstract:
The overarching objective of the proposed studies is to identify and characterize early premalignant changes in
breast tissues from women that carry genetic alterations associated with a high risk of breast cancer to ultimately
develop strategies to detect and prevent the development of breast cancer. To accomplish this goal, we have
optimized three technologies to profile single breast mammary cells (MECs): (1) CyTOF mass cytometry to allow
tracking in parallel of >30 cell lineage and proliferation markers, (2) single cell RNA sequencing to identify
expression programs of cell populations enriched in mutation-carriers, and (3) multi-plex cyclic immunofluorescence
imaging (CyCIF) to simultaneous image >50 markers in situ. These technologies make it possible to detect
differences in small populations of cells that would be masked by bulk population analyses. To date, we have
profiled breast tissues from over 30 women with wild-type or mutant BRCA1 or BRCA2 by CyTOF and have
identified distinct, previously unrecognized subpopulations of cells that are enriched in breast tissues from BRCA1
and/or BRCA2 carriers. These enriched subpopulations may represent cells that are either directly on the path to
malignancy or indirectly contribute to the development of cancer in these high-risk women. We have identified RNA
signatures associated with these enriched subpopulations, which include surface markers to isolate them from
breast tissue to investigate both these possibilities and to track them within breast tumors. The signatures
associated with one of the enriched populations have provided clues as to the basis for their accumulation, as well
as potential strategies to prevent their accumulation. Using CyCIF, we have been able to identify enriched
subpopulations of cells in situ within breast tissues and track their association with aberrant histologies. We have
also developed organoid cultures that maintain all of the major MEC lineages as well as the BRCA1/2-enriched
populations, and that are able to reconstitute glandular structures in immunocompromised mice. We believe that
these tools provide an unprecedented opportunity to track the development of human cancer. In the proposed
studies, we will investigate whether and how the BRCA1/2+/mut-enriched subpopulations contribute to
tumorigenesis in mutation carriers. We will also investigate the basis for the enrichment of these populations and
the contribution of DNA damage to their enrichment. Later stage studies will focus on the development of strategies
to interfere with tumor progression, and importantly to develop novel diagnostic strategies to inform on the timing of
prophylactic interventions. In addition, we will examine tissues from women who carry mutations in other breast
cancer predisposition genes to establish whether similar subpopulations are detected in other high-risk individuals.
And lastly, we will examine the possibility that these cells represent cells-of-origin of sporadic breast tumors that
arise more broadly in the population.

Public health relevance
Project Narrative: The only effective means of breast cancer prevention in women with inherited BRCA mutations is prophylactic mastectomy, which, while effective, raises issues relating to quality of life and other psychological and physical consequences. The overarching objective of this application is to develop strategies to detect and eliminate pre-malignant cells in breast tissues from high-risk women. To accomplish this goal, we have used state-of- the-art single-cell technologies to detect and isolate subpopulations of breast cells that accumulate in BRCA1 and BRCA2 mutation carriers and propose studies to determine how these subpopulations contribute to tumor development and what causes their accumulation in order to develop strategies to interfere with cancer development in high-risk women.